Modulation of Teff/Treg cells by novel PKC-theta allosteric inhibitory strategies

DESCRIPTION (provided by applicant): Protein kinase C theta (PKCθ) is a PKC family member most abundant in T cells, where it plays critical roles in effector T (Teff) cell activation PKCθ uniquely localizes to the center of the T cell immunological synapse (IS) via physical association with CD28, and this localization is required for downstream PKCθ-mediated signaling. In vivo analysis of PKCθ-deficient mice revealed a selective requirement of PKCθ in some (Th2- and Th17- mediated inflammation, allograft rejection and graft vs. host disease) but not other (Th1/CTL antiviral and graft vs. leukemia) immune responses. Intriguingly, PKCθ was recently found to be excluded from the IS of induced Treg cells (iTregs) and to inhibit their suppressive function, including in humans. Our preliminary studies show that strategies, which disrupt the PKCθ-CD28 interaction and displace PKCθ from the IS, including novel, previously uncharacterized PKCθ allosteric inhibitors (AI), enhance the in vitro differentiation and suppressive function of mouse iTregs. Our new preliminary data suggest that the same strategies have similar effects on human T cells. These findings point to the high promise of PKCθ as a selective drug target for immunosuppression of harmful T cell-mediated autoimmunity, inflammation, and GvHD, where inhibitory strategies are predicted to act synergistically to inhibit pathogenic T cells and promote Treg function, without interfering with beneficial antiviral protective immunity. Here, we will investigate in detail the potential therapeutic value of blocking the PKCθ-CD28 interaction in a mouse model of Th2 cell-mediated allergic lung inflammation, and the selective and seemingly opposite roles of PKCθ in the in vitro differentiation and function of human Teffs and Tregs, respectively. These studies will address the working hypothesis that blockade of the PKCθ-CD28 interaction inhibits the differentiation and function of pathogenic T cells and promotes the function of Tregs in both mice and humans, thereby achieving a beneficial synergetic effect against harmful T cell- mediated inflammatory responses. In Aim 1, we will employ a dominant negative PKCθ mutant and novel PKCθ AI to study the resulting effects on the development and manifestation of Th2-mediated allergic lung inflammation in intact mice, bone marrow chimeric mice, or by using adoptive T cell transfers, including the use of TCR-transgenic and FoxP3eGFP reporter mice. In Aim 2, we will use, for the first time, the same blocking strategies of Aim 1 to disrupt the TCR/CD28-induced PKCθ-CD28 interaction in human CD4+ T cells, and evaluate their effect on the in vitro differentiation and function of human blood-derived Teff and Treg cells. This project will extend our understanding of the importance of the PKCθ-CD28 interaction, which was discovered in our laboratory, and its biological relevance for the differentiation and function of both Teff and Treg cells, importantly extending these findings to human T cells. It will also represent the first detailed analysis of novel PKCθ AI on T cell responses, and may pave the way to the development of new, highly selective therapeutic strategies to treat T cell-mediated allergies, autoimmune, diseases, and GvHD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Protein kinase C-theta is an enzyme expressed predominantly in T lymphocytes of the immune system, where it is required for the function of most pathogenic (disease-causing) effector T cells, but is inhibitory for the function of disease-suppressing regulatory T cells. Since inhibition of T cells that cause allergies, autoimmune diseases, and transplant rejection and, conversely, promotion of regulatory T cells that suppress these responses is a highly desirable clinical goal, we will analyze in this project the effects of two novel PKC-theta inhibitory strategies in a mouse model of human asthma, and on the activation and function of human effector and regulatory T cells in cell culture.